The role of vascular failure and biomechanical stress in the development, progression and healing of osteochondritis dissecans lesions

PROJECT SUMMARY/ABSTRACT
Ostechondritis dissecans (OCD) is a developmental orthopaedic disease affecting children and young adults. It
is characterized by formation of osteochondral flaps or fragments within joints which causes pain and disability
and predisposes to early onset osteoarthritis. Although recent studies demonstrated that discrete areas of
epiphyseal cartilage necrosis (termed osteochondrosis), caused by focal failure of vascular supply, are the
clinically silent precursor lesions of OCD, it is yet to be established how the extent of the inciting vascular
failure, along with exposure to biomechanical trauma, determine whether these lesions heal or progress to
clinically apparent disease.
The overall objective of this proposal is to use porcine models to understand factors that influence the
development, progression, and healing of OCD lesions. To achieve this objective, we will use two specific aims
to test our central hypothesis that the extent of ischemic epiphyseal cartilage necrosis determines the
development of OCD, and that lesion progression is influenced by biomechanical stress. Specifically, our aims
have been designed (1) to investigate the relationship between the severity of vascular injury to the femoral
trochlear epiphyseal cartilage and the formation and progression of OCD precursor lesions and (2) to
determine the role that low vs. high impact biomechanical stress plays in the formation of subclinical
osteochondrosis lesions and their progression to clinically apparent OCD.
Our study will establish how the extent of vascular failure and exposure to biomechanical stress drive the
clinical course of OCD and determine characteristic gene expression profiles across OCD lesion types.
Conducting these studies in a large animal model will ensure timely translation of our results to inform clinical
decision making in human patients, and will also help establish controlled exercise as a component of non-
operative treatment. Importantly, these findings will also have applicability to other juvenile orthopaedic
disorders of vascular origin such as Legg-Calvé-Perthes disease.

Public health relevance
PROJECT NARRATIVE Ostechondritis dissecans (OCD) is a developmental orthopaedic disease affecting children and young adults. It is characterized by formation of osteochondral flaps or fragments within joints which cause pain and disability and predispose to early onset osteoarthritis. In the current proposal, our objective is to establish how alterations in the vascular supply to the epiphyseal growth cartilage, along with biomechanical trauma, contribute to the development, progression, and healing of OCD lesions.